Alterations in neuronal metabolic pathways contribute to human cognitive aging and are exacerbated in Alzheimer's disease

PROJECT SUMMARY
To find therapies for altering the course of age-related diseases, experimental methods that discriminate
between normal and pathological aging processes are needed. Nowhere is this need more urgent than in the
quest for effective treatments for Alzheimer’s disease (AD). Despite decades of research, AD remains a
debilitating, progressive, and ultimately fatal dementia with few and ineffective disease-modifying treatment
options. The vast majority of cases (~95%) are sporadic, with no known cause aside from advanced age. As
the population over age 65 grows, the burden of AD is destined to grow in lockstep. Avoiding this fate requires
rethinking why existing efforts have been ineffective.
Although AD is a disease of aged human brains, many AD studies fail to parse aging from disease. We have
developed a system that lets us model aspects of human age in vitro: induced neurons (iNs). Once matured,
neurons of the brain never again replicate their genome or divide. As such, post-mitotic neurons downregulate
cell-cycle mediated metabolic pathways used for the synthesis of DNA building blocks, deoxyribonucleotides
(dNTs) and become reliant on the salvage of ribonucleotides (rNTs). I asked if these fundamentally important
homeostatic processes are maintained over the human lifespan or in AD. Multiple experimental approaches on
iNs derived from 13 sporadic AD (sAD) patients against 13 cognitively normal, age-match individuals (CN),
revealed dramatic differences in NT pools, with a significant increase in rNTs in CNs relative to young healthy
iNs. This effect was even further exacerbated in AD iNs. I ask here if the dramatic increases in rNTs result in
increased ribo-substitution in nuclear and mitochondrial DNA, thus promoting increased DNA damage and
bioenergetic dysfunction in age and AD. Further, I observed significant differential expression of key cell cycle
and metabolic genes such as CDK1 and RRM1, which I have confirmed at the protein level. Our proposal, for
the first time, incorporates long noted pathological observations of chromosomal instability and presence of
cell-cycle markers in AD into a testable model system that provides a mechanistic basis for the development of
sporadic AD.
In addition to the critical scientific advances this proposal aims to achieve, I will also contribute new powerful
new tools and datasets to the fields of aging and AD. I have adapted our recently developed repair-seq
technology to quantify ribo-substitution in aged and AD iNs. I will further map epigenetic drift over the human
lifespan in neurons and quantify the neuronal capacity to generate new methyl groups for non-genetic
regulation of transcription.

Public health relevance
PROJECT NARRATIVE Neurons of the brain age in parallel with the individual and we can model changes in aged and diseased human neurons in a dish. I have reproducible evidence from multiple genetically distinct individuals with Alzheimer’s disease (AD), that shows the metabolic pathways involved in making the DNA building blocks are altered, potentially leading to increased DNA damage and other metabolic dysfunction. With new technologies, we will quantify changes in DNA quality, investigate two key regulators of this metabolic pathway, and profile non-genetic DNA changes associated with age and AD.